Deciphering molecular details of cellular sugar transport and their roles in disease

Abstract
Sugars, in particular glucose, are not only a ubiquitous cellular fuel source in virtually all organisms, but
also serve as critical metabolic intermediates in which activated glucose molecules are transported to
the ER and Golgi and used for glycosylating proteins, lipids and other organic compounds as part of
the biosynthetic-secretory pathway. To accomplish these diverse and localized functions, the body
utilizes membrane transporters and channels to transfer glucose and its intermediates across the
otherwise impermeable membrane lipid bilayer that surrounds all cells and organelles. Secondary
active transporters are key mediators in this process. Alternatively, the Voltage Dependent Anion
Channel funnels glucose intermediates into the mitochondria where they enter the TCA cycle for the
production of ATP. In their essential function for physiology, these proteins are implicated in numerous
diseases and are designated targets for pharmaceutical compounds.
In the parent R35 entitled, “Deciphering molecular details of cellular sugar transport and their
roles in disease” we aim to characterize the structure and function of several families of transporters
involved in cellular sugar and metabolite transport. Specifically, we want to study the Sodium Glucose
Cotransporter (SGLT), Nucleotide Sugar Transporters (NST) and Sialic Acid Transporter (SiaT) and
the Voltage-Dependent Anion Channel (VDAC). Human SGLTs are well known targets for treating Type
II diabetes, but the molecular details of inhibition and the functional differences between isoforms are
not well understood. This is in large part due to the lack of structural information. NSTs import various
activated sugar compounds into the Golgi and ER, whereas SiaT serves to import scavenged sialic
acids from its host. Differences between eukaryotic and pathogen NSTs could be exploited for
therapeutic purposes. However, this family of transporters is still largely uncharacterized. VDAC is the
central mediator of metabolite exchange through the outer mitochondrial membrane. Despite this
critical role, key aspects of its functional gating and substrate transport are not well understood. Again,
we hope that resolving additional structures of VDAC will help to answer these remaining questions.
Our structural biology approach is complemented by functional studies to obtain a complete picture of
sugar transport at an atomic resolution. We need to assess the functionality of heterologously-
expressed proteins during the early stages of project. After obtaining the structures, we plan to
interogate them by inserting mutations at critical sites identified in the structures. Furthermore, we plan
to screen small-molecules as potential inhibitors. Electrophysiology on solid-supported membranes is
a suitable highthroughput method for all stages of the proposed project.

Public health relevance
PROJECT NARRATIVE We aim to characterize the structure and function of several families of transporters involved in cellular sugar and metabolite transport. We plan to use a solid-supported membrane system (Nan]i[on SURFE²R N1) to measure substrate-induced currents as an alternative to radioligand transport assays. It will allow us to screen transporter expression in cells, as well as to determine functional properties like substrate transport and inhibitor binding on purified protein reconstituted into proteoliposomes in a high-throughput fashion.